MOLECULAR MECHANISMS OF AUTOIMMUNE DISEASE IN MAN AND ANIMAL MODELS

We are studying the cellular and molecular basis of autoimmune diseases with two purposes. First, we want to establish the pathogenic role and antigen-specificity of T cells that cause autoimmune diseases such as multiple sclerosis, myasthenia gravis, insulin-dependent diabetes, among others. Second, we would like to determine the feasibility of specific antigen- induced apoptosis as a means of treating such autoimmune diseases. To these ends, we have made progress in the following areas: 1) we have successfully established the marmoset model of experimental allergic encephalomyelitis at the NIH; 2) we found that an important component of the marmoset disease is the formation of a pathogenic antibody against a protein component of the insulating sheath (myelin) of nerves in the central nervous system; 3) we are taking the first steps towards a clinical trial of antigen-induced apoptosis in multiple sclerosis, and 4) we are creating a transgenic mouse model of myasthenia gravis in order to test the efficacy of antigen-induced apoptosis. As part of these studies we are also trying to understand the regulation of antigen-induced death by T cell receptor stimulation. These studies should yield important new insights into the pathogenesis and treatment of autoimmune diseases which is a widespread health problem in the U.S. particularly among working women.